Biomineralization potential of inorganic polymer for bone tissue regenerative engineering

Biomineralization potential of inorganic polymer for bone tissue regenerative engineering
Project Abstract
Bone grafting is the second most common tissue transplantation procedure, with 2.2 million procedures being
conducted worldwide. The clinical gold standard for treating large non-healing craniofacial defects is to harvest
and transplant autogenous grafts. However, the supply of autogenous grafts is limited, and post-surgery
morbidities are frequent. Due to a reliance on titanium-based, polymer-based, and ceramic-based orthopaedic
implants, standard synthetic bone scaffolds often result in complications such as infection or bone degeneration
due to a mismatch in both geometry and physical properties between the implant and the surrounding natural
bone structure. Therefore, there is a gap of knowledge in novel multiscale materials for tissue regenerative
engineering to mitigate bone loss, and promote bone proliferation around the host bone structure. The long-
term research goal is to discover novel multiscale bone scaffolds by integrating composite materials science,
physical sciences, and translational medicine. My long-term career goal is to enable tissue fabrication for bone
regeneration through the integration of advanced materials science, physical sciences, and translational
medicine. I plan to focus on a new class of materials, inorganic polymers that are synthesized at low
temperatures by dissolving an aluminosilicate source in an alkali-silicate solution. My research hypothesis is
inorganic polymer materials can be used to mimic the multiscale microstructure and mechanical behavior of
compact bone and induce bone regeneration thanks to their nanoscale structure, mesoporosity, and excellent
mechanical properties. Nanoscale structural features are frequently linked to improved osseointegrativity
whereas as micropores promote cell migration, vascularization and innervation. My preliminary results have
shown that the pore size and total porosity of inorganic polymer composites can be modified by adjusting the
mix design and the processing route. Unreinforced pure inorganic polymer exhibits stiffness and strength values
close to that of compact bone, suggesting that a closer match in mechanical properties can be obtained through
materials design. My work has shown that inorganic polymer, is biocompatible with mouse fibroblast cells and
human mesenchymal cells. However, what is yet unknown are the cell-wall interactions, the osteoblast
mineralization mechanisms, and the in-vivo performance for inorganic polymer scaffolds. Therefore, this
discovery has laid the groundwork to move to translational regenerative bioengineering to elucidate the factors
driving the biocompatibility of novel engineered inorganic polymer-based scaffold. Two specific research aims
are proposed. Aim One will yield optimized synthesis routes for biocompatible inorganic polymer-based bone
scaffolds with a fundamental understanding of the mechanisms of cell attachment and migration in inorganic
polymer scaffolds. Aim Two will enable a fundamental understanding of osteoblast differentiation and
mineralization mechanisms in inorganic polymer nanocomposites. Aim Three will investigate the potential of
inorganic polymer scaffolds to accelerate the healing of complex craniofacial defects in-vivo using rat animal
models. The proposed RO3 project will yield novel materials for bone tissue regenerative engineering.

Public health relevance
PROJECT NARRATIVE This project is relevant to public health because of the high demand for advanced synthetic bone scaffolds— bone grafting is the second most common tissue transplantation procedure worldwide. This highly innovative project will investigate new bone scaffolds that closely math the geometry and physical properties of native bone, thanks to a close integration between inorganic chemistry and advanced nanocomposite synthesis. This high-risk, high-reward research will transform the field of tissue regenerative engineering, yield a new generation of bone scaffolds with a better integration around the host bone. 1|Page